Chromatin Regulation of Tissue Regeneration and Stem Cell Function

Genomic regulators such as transcription factors and chromatin-modifying enzymes work together to
instruct cell fate during developmental processes, including both the routine cell turnover that occurs during
homeostasis and the major tissue replacement and repatterning that occurs during regeneration. One specific
group of chromatin-modifying complexes whose activity is strongly associated with gene expression is the
Set1/MLL family of histone methyltransferases. These enzyme complexes share a core of several essential
subunits, yet each particular enzyme (Set1, MLL1, MLL2, etc.) is functionally non-redundant in multicellular
animals i.e., individual null mutations are lethal. These data and others, including some from my laboratory,
indicate that each Set1/MLL complex regulates its own distinct set of genes. However, many of the molecular
and mechanistic details driving this biochemical and functional specificity remain unknown.
To uncover the fundamental molecular mechanisms underlying this process, my laboratory studies the
planarian model of animal regeneration. Planarians are free-living flatworms with incredible regenerative
capacities. They are also amenable to genetic perturbation through RNAi, easily dissociated for single cell
analyses, and encode chromatin modifying proteins with strong homology to those of other organisms. For
example, planarian Set1 and MLL1/2 enzymes show strong sequence homology to their mammalian
counterparts and my previous research has shown that loss of either enzyme leads to loss of their conserved
histone modifying activity, trimethylation of histone H3 at lysine 4 (H3K4me3). Moreover, we find that each
enzyme targets a specific set of genes that correlate with their phenotype after enzyme loss. Specifically, loss
of MLL1/2 through RNAi of its transcript leads to loss of H3K4me3 at highly conserved cilia genes as well as
loss of cilia and ciliated cells. However, we do not know how MLL1/2 targets these cilia genes specifically in
vivo. To begin identifying the molecular and mechanistic basis of this targeting, we first need to characterize
the planarian MLL1/2 complex in terms of its biochemical composition and function.
Notably, the phenotype induced in planarians after RNAi of a core Set1/MLL complex subunit, dpy-30,
may provide an opportunity to uncover the mechanism that distinguishes Set1 from MLL1/2 function in vivo. To
test this idea, I have recruited a promising undergraduate student to identify planarian DPY-30 interacting
proteins. He will begin by cloning the two planarian versions of DPY-30 with an epitope tag. He will then
express these planarian proteins in mammalian cells and ask if they stably interact with mammalian MLL1/2
proteins and form a functional histone methyltransferase complex. These studies will inform whether planarian
DPY-30 is required MLL1/2, but not Set1, assembly and/or function as a histone methyltransferase complex.
This project will also allow Ethan to gain the experience and skills needed to build a career in biomedical
research.

Public health relevance
Research in my lab leverages the fundamental protein homology yet remarkable regenerative and developmental abilities of planarian flatworms to uncover fundamental mechanisms that link external signals to functional changes in gene expression. Our previous data indicated that chromatin modifying protein MLL1/2 maintains its conserved enzymatic role in planarians and at the same time revealed novel genomic targets of this enzyme. We have recruited a promising undergraduate student to test the biochemical homology of the planarian MLL1/2 complex by assessing the ability of planarian MLL1/2 complex subunits to interact with mammalian MLL1/2 complex proteins in a functional way.